Monitoring neuronal activity with a blood test - Released Markers of Activity (RMA)

Project Summary
Blood tests are among the most common clinical tools due to their low cost, simplicity, and ability to observe
many markers at once. However, currently blood tests can only monitor a fraction of physiological processes
that happen to have a serum marker. What if we made synthetic serum markers that can track other physiological
processes? The PI has recently developed such markers called Released Markers of Activity or RMAs. RMAs
are expressed in the brain in response to a physiological process, such as neuronal activity, but then exit into
blood for simple detection. In our preliminary data, RMAs could monitor expression in as few as 10s-100s of
cells in the brain and show signal levels up to 39,000-fold over baseline when monitoring a single brain region.
The PI was able to use RMAs to measure neuronal (c-Fos) activity in specific brain regions with a simple blood
test. Since this discovery, our laboratory has been working on the new paradigm of ‘imaging’ the brain with blood
sampling. This approach has many advantages. First, typical reporters need to be measured within the brain
where access is difficult and the signal is compromised by surrounding tissue. Our key innovation is to keep
record of the RMA’s location in the brain, but access it with a simple blood test that is not compromised by the
skull, tissue scattering, or high background from surrounding cells. Second, there is a large number of genes in
each cell and tens of distinct brain regions, but available reporters can at most represent only a few signals (e.g.
a few colors of fluorescent proteins). RMAs use biochemical detection and thus can be massively multiplexed
similarly to how thousands of proteins can be detected in blood simultaneously using mass spectrometry. Third,
RMAs can surveil large brain regions, unlike invasive locally-implanted devices. Finally, RMAs are inexpensive
and easy to use - they are genetically encoded proteins and can use simple equipment such as a plate reader.
The PI has a track record of developing innovative technologies that blend interfaces of multiple disciplines, such
as genetically-encoded MRI contrast agents, Acoustically Targeted Chemogenetics (ATAC) for noninvasive neu-
romodulation, or acoustically-targeted viral vectors (AAV.FUS). In this proposal, the PI will use cutting-edge
single-molecule protein detection to increase sensitivity of RMAs from 10s-100s of cells to single neurons. Then
we will develop ‘fast’ RMAs that can measure more rapid changes in gene expression. Finally, we will enable
massively-multiplexed readout of RMAs using peptide barcoding to track gene expression in multiple brain re-
gions at once, and, if feasible, in single cells in whole brain regions. Using RMAs we will enable a previously
inaccessible study. We will monitor activity of neurons encoding a fear memory and measure whether activation
of these neurons in safe environment is responsible for fear renewal, a finding that would have broad implications
for treatment of anxiety disorders. New reporters, such as fluorescent proteins historically enabled broad discov-
ery. RMAs too have the potential to transform broad areas of science as they can be adapted to noninvasively
track different in vivo systems and tissues with single-cell sensitivity, massive multiplexity, and low cost.

Public health relevance
Project narrative Blood tests are among the most common clinical tools due to their low cost, simplicity, and ability to observe many markers at once. However, currently blood tests can only monitor a fraction of physiological processes that happen to have a serum marker. Here, we are developing synthetic markers that can exit from the brain into blood to and in the process measure critical aspects of brain physiology with a simple blood test.